Effectiveness and Implementation of a Research Tested Mobile Produce Market Designed to Improve Diet in Underserved Communities

Abstract
This administrative supplement will support the development of Christina Kasprzak’s research and professional
skills and provide her with postdoctoral training. There are no proposed changes to the scope or human
subjects of the parent grant and the abstract remains as follows: Lower-income and minority groups face
significant health disparities with respect to obesity, cancer, heart disease and other diet-related chronic
conditions. Poor diets, low in fruits and vegetables (F&V) and high in saturated fat, sodium and sugar,
contribute to many of the health problems faced by vulnerable groups. While socioeconomic status and other
individual level factors (i.e., food preferences, time and skills to prepare healthy food, etc.) can lead to reduced
F&V consumption, these must be viewed in an environmental context. Compared with higher-income
neighborhoods, lower-income and minority neighborhoods are less likely to have stores that sell a variety of
F&V and other healthy foods. When stores are available, produce may not be affordable, high quality or
culturally appropriate. Farmers’ markets and mobile produce markets (MM) have become increasingly popular
strategies to alleviate food access concerns in underserved communities. However, it is unclear if these
programs have the necessary components to have an appreciable impact on diet. The research team recently
completed one of the first randomized controlled trials of a MM program called the Veggie Van (VV). VV
delivered boxes of fresh, locally grown produce and food-focused education to communities with significant
barriers to F&V consumption including availability, affordability, quality and knowledge. In this small cluster-
randomized trial in 12 communities (N=201), the team saw impressive changes in F&V intake with intervention
participants eating almost 1 more cups per day of F&Vs than the control group. Intervention participants also
reported increases in perceived access to healthy foods and VV customers attributed many dietary changes to
the MM program. While these results are very promising, it is important to test the effectiveness of the VV
program when implemented by different organizations in multiple communities. If shown to be effective, the
team can create a research-tested intervention toolkit which can be disseminated to communities across the
country. For this research, they identified 8 organizations nationwide that are well-qualified to implement the
VV model. Organizations will identify appropriate sites for MM deliveries (32 total), which will be randomized to
either an implementation or planning condition. With the help of the team’s technical assistance and provided
funding, partner organizations will engage community members in the process and initiate a MM program. The
research team will use a Type 1 Hybrid Effectiveness-Implementation to measure effectiveness (diet, BMI,
dermal carotenoids) and implementation (customer reach and sales, process measures, qualitative interviews
with MM staff). They will also examine sustainability of MM financial models and determine implementation
standards (i.e., dose needed to maintain impact) for inclusion in their MM toolkit for future dissemination.

Public health relevance
Narrative Our research demonstrated that a mobile produce market can have a significant positive impact on diets of residents in lower-income communities. We want to test this program more widely to determine if the effect can be replicated and develop a best-practices toolkit to help others sustainably implement the program.